Cancer Research Training & Education Core

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION – SUMMARY/ABSTRACT The goal of the Cancer Research Training and Education Coordination Core (CRTEC) is to provide, integrate, and coordinate education, training, and career development activities across all Research Programs within the UVACC community. It does so in the setting of a highly collaborative cross-campus education and professional development portfolio offered through the UVA Schools of Medicine, Engineering and Applied Science, Arts & Science, Data Sciences, and Education. With this strong infrastructure in hand, the CRTEC Core partners with the CCSG Research Programs and Shared Resources to provide trainees with a program of study built on a platform of impactful cancer research, an innovative cancer-focused curriculum, and robust career development programs. The CRTEC also works with departments, divisions, and UVACC Members to offer strong mentoring and career development for junior faculty in the UVACC. Finally, it coordinates cancer- focused educational and experiential initiatives for grade and high school students, and partners with the Research Programs and Community Outreach and Engagement (COE) Core to provide continued education for health care professionals on-site and within the catchment area. In each of these endeavors, the CRTEC Core places value on engaging a varied community of learners that will enhance the research and educational enterprise of the UVACC. Our education and training programs have met with great success during the previous grant cycle, with strong publication records, numerous awards and fellowships, competitive postdoctoral and faculty positions for our trainees; advancement for our junior faculty; and training for our health care professionals. These accomplishments will be augmented by several new initiatives planned for the next grant cycle, which include (1) expanding our footprint in K-12 education; (2) partnering with COE to use telemedicine and the Project ECHO platform to help educate health care providers in our catchment area; and (3) formalizing a summer research program for faculty from institutions that are not research intensive that will open doors to new multi-institutional collaborations and encourage their students to pursue careers in cancer research.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.